Adminitrative Core

ADMINISTRATIVE CORE – PROJECT SUMMARY / ABSTRACT
The overall goal of the Administrative Core (Admin) is to coordinate the development, high impact functioning,
and sustainability of the COBRE for Restoration of Neural-Based Function at the Medical University of South
Carolina (MUSC) with standing as national and international leaders. In order for the COBRE to exert a
sustained, powerful influence on the field of restoration of neural-based function (RNF), we oversee numerous
individual component functions to ensure a cohesive program that aligns with the needs of our research user
base while aligning COBRE initiatives to take optimal advantage of the strategic research and faculty
development resources of the university. Our work is organized under these Specific Aims: 1) Leadership and
Oversight: the Executive Committee (EC) provides balanced leadership, program integration, oversight and
accountability for all COBRE programs, services, and interactions. The EC discusses and confirms all strategic
decisions, issues approvals for all independent resource requests and prioritizes and approves the annual
budget. Oversight of the Executive Committee is provided by the Advisory Council. 2) Operations and Fiscal
Management: the PD/PI and the Admin staff are responsible for operations. 3) Strategic Planning and
Sustainability: Admin provides scientific and programmatic leadership for success and sustainability via three
sub-aims to: a) Lead strategic planning and implementation; b) Promote activities that increase and diversify the
research funding portfolio; and c) Achieve financial independence for the center by optimizing tailored funding
and reimbursement models. 4) Program Evaluation: The Evaluation Director is responsible for developing an
integrated, long-term evaluation plan to ensure quality control of programs and continual improvement
responsive to research community needs as well as document the impact of the COBRE. 5) Pilot Project
Funding: Admin will continue to administer our successful Pilot Project Program to attract new and/or established
investigators and enable them to generate preliminary data and access COBRE cores with goals of obtaining
competitive extramural research grants and publishing peer-reviewed manuscripts in high quality journals. We
will give priority to early-stage investigators, investigators new to RNF research, and diverse investigators.